Boosting mind-body mechanisms for mitigating autonomic dysfunction in migraine

Abstract
Migraine (MIG) is a prevalent (15-20%) and highly disabling disorder, with complex neurobiological
underpinnings characterized by autonomic dysregulation. Mindfulness meditation (MM) has been proposed as
a behavioral intervention that may improve autonomic functioning. Our own data, and those of others, found
enhanced parasympathetic drive (as evidenced by higher levels of high-frequency heart rate variability, or HF-
HRV), after only 8 weeks of meditation training. In addition, meditation training promotes improved emotion
regulation and corresponding decreased activation of the amygdala in response to stressors, again as shown
by our own data and those of others. Normalization of autonomic functioning and reduction of amygdala
response to stressors may be an important therapeutic target in migraineurs. Multimodal approaches have
shown improved clinical outcomes, and have been recommended in the recent Institute of Medicine report on
pain. We propose that this is also the case for mind-body therapies. MM has shown promise for migraine, and
likely operates by top-down mechanisms, potentially reducing amygdala reactivity as well as enhancing
autonomic functioning, both peripherally (as assessed with HF-HRV) and centrally (as assessed with fMRI in
the Central Autonomic Network, or CAN).
Additionally, bottom-up therapies such as invasive and non-invasive auricular transcutaneous vagus nerve
stimulation (tVNS) also reduce migraine frequency and disability. In tVNS, vagal afference relayed to nucleus
tractus solitarii (NTS) in the medulla may modulate trigeminal sensory complex excitability and hyperexcitability
in higher brain structures (i.e., a “bottom-up” pathway). Furthermore, the dorsal medullary vagal system
operates in synchrony with respiration: NTS receiving inhibitory inputs from medullary ventral respiratory group
(VRG) nuclei during inhalation, and facilitatory input during expiration. This is a critically-important feature of
this circuitry, as it suggests that interventions utilizing this NTS pathway should be synchronized with
respiration. Hence, our group developed Respiratory-gated Auricular Vagal Afferent Nerve Stimulation
(RAVANS), which optimizes tVNS targeting of NTS by stimulating only during the expiratory phase. Thus,
RAVANS tVNS incorporates bottom-up modulation of cortical/subcortical hyperexcitability. In sum, we propose
that MM training incorporating RAVANS tVNS will have a synergistic effect in enhancing (both central and
peripheral) autonomic functioning and in mitigating amygdalar hyperactivity in response to stressors in patients
with migraine.